Lateral Flow-Electrochemiluminescent (LF-ECL) Test Strips and Portable Reader for Ultrasensitive Foodborne Pathogen Detection

Summary Abstract
Nanohmics proposes to couple the extreme sensitivity of electrochemiluminescence (ECL) from traditional ruthenium
trisbipyridine (Ru(bpy)3) or even more promising quantum dot (Qdot)-based ECL sensitivity with the portability,
convenience and speed (~ 15 minutes) of lateral flow (LF) test strips to produce a menu of ultrasensitive assays for
detection of the major foodborne pathogenic bacteria and viruses. LF strip assays are known for being rapid, highly
affordable, and facile onsite diagnostics, but generally lack sensitivity and may miss detection of foodborne pathogens
(false negative results) at low levels even in time-consuming enrichment cultures. In some cases, LF strip developers have
turned to fluorescence for added sensitivity. But, fluorescence has innate autofluorescent background from the excitation
of other biological materials in samples, thus limiting its sensitivity. And although chemiluminescence (CL) can be
ultrasensitive due to its initial black background and high signal to noise ratios (SNRs), CL is difficult to control spatially on
a test strip and requires temporal delays to allow it to reach stable equilibrium prior to measurement which limits
reproducibility. However, ECL is simple to control by controlling the working electrode voltage (only about 1.25V), thus
enabling battery-operated handheld readers too. ECL can amplify or accrue the signal over time each time the Ru(bpy)3
redox “wheel” is turned electrically to release another red photon, thus giving sensitivity comparable to radioisotopic
methods when the ECL signal is integrated over time. Newer Qdot-based ECL techniques promise as much as a million-
fold increase in ECL over Ru(bpy)3-antibody or aptamer tags as well. Thus, Nanohmics proposes to build on its recent CDC-
funded Phase I and DoD/OSD-funded Phase II SBIR contracts that are enabling it to develop highly sensitive antibody LF
test strips for Influenza A/B and SARS-CoV-2 fluorescent and ECL LF assays using Qdots. These Qdot-LF test strips will be
compared with antibody- and DNA aptamer-Ru(bpy)3-based LF test strips in terms of ECL output and limits of detection
(LOD) for foodborne pathogens (initially Listeria and Salmonella) in Phase I. The winning LF strip design will be used for
development of a portable ECL LF test strip reader and more foodborne bacterial and virus assays in Phase II to deliver to
the public the most sensitive and rapid handheld onsite foodborne pathogen tests to aid in rapid detection and control of
foodborne disease outbreaks.

Public health relevance
Project Narrative The CDC estimates that about 1 in 6 Americans (48 million people) become sick, 128,000 are hospitalized, and 3,000 die from 31 different known foodborne pathogens. Therefore, food safety testing is an enterprise that desires “zero tolerance” in which the presence of even one pathogenic microbe is unacceptable. This fact drives the need for ultrasensitivity to minimize or potentially eliminate culture enrichment time. While PCR is highly sensitive and accurate, running greater than 30-40 cycles can produce anomalous false positives and PCR is relatively expensive, slow and not generally portable compared to less expensive immunochromatographic or lateral flow (LF) test strips which can be used on site. Unfortunately, colloidal gold and even fluorescent test strips are not nearly as sensitive as PCR. Thus, Nanohmics proposes to develop LF test strips for the major foodborne pathogens using commercial antibodies and/or the PI’s extant proven DNA aptamers coupled to electrochemiluminescent (ECL) Ru(bpy)3 or quantum dot (Qdot) tags for further enhanced ECL to provide rapid (15 min.), ultrasensitive, inexpensive and highly portable onsite detection of foodborne pathogen outbreaks and curtail their spread before they reach epidemic levels or bankrupt food producers.